Advancing Sepsis Biology and Care Through the Power of Modern Biobanks

PROJECT SUMMARY
Sepsis is a leading cause of hospital admission and mortality worldwide, posing a significant economic burden.
Despite extensive efforts and numerous clinical trials over the past 30 years, no approved drugs for sepsis exist,
largely due to inadequate knowledge of the factors that contribute to sepsis clinical heterogeneity and a limited
mechanistic understanding of sepsis biology. Human genomics studies can narrow this gap. However, previous
large-scale human genomics studies of sepsis lack reproducibility, possibly due to poor phenotyping and lack of
accounting for confounding non-genetic factors. They also failed to bring mechanistic understanding of the role
of genetic factors in sepsis biology limiting their utility for advancing sepsis biology and care. The overarching
goal of the current research program is to gain a holistic picture of the complex factors contributing to sepsis
pathogenesis by determining how genetic factors work with clinical, behavioral, and social determinants of health
to shape sepsis risk and outcomes and uncovering the biological mechanisms that connect genetic variants to
sepsis risk. Modern biobanks are a powerful tool for achieving this goal by providing simultaneous access to
patients’ genetic, clinical history, and sociodemographic data. In the next five years: I) We will leverage large
and ancestrally diverse electronic health record (EHR)-linked biobanks to define sepsis case-control status
based on rigorous clinical criteria, run genetic association tests, and discover novel sepsis risk variants. II) We
will stratify cases and controls to no-, low-, or high-comorbidity strata and will repeat our genetic analyses
accounting for clinical comorbidity. We will also leverage extensive behavioral and social determinants of health
data in biobanks, to account for the potential confounding effect of these factors on sepsis outcomes. Finally, we
will assess the interaction between genetic and clinical, behavioral, and social risk factors of sepsis to understand
how they work together to shape disease risk. III) We will combine human genomics data with clinical laboratory
measurements and molecular phenotypes data from sepsis patients to determine the effect of genetic variants
on the regulation of physiological and molecular functions in sepsis and identify the mechanisms that connect
variants to disease. Achieving these goals will lead to a better understanding of sepsis biology and could aid the
identification of novel targets in a field in which existing approaches to drug development have yet to succeed.
Additionally, my program will provide a much-needed framework for leveraging and combining the wealth of
diverse data that is available through modern biobanks to advance human health. This program builds on my
deep expertise in statistical and functional genomics and the resources and capabilities of my group. It is further
supported through collaborations with experts in sepsis clinical care, phenotyping using EHRs, epidemiology,
and functional genomics. Following this proposal, we will extend the clinical utility of our findings by
investigating the genetics of drug response in sepsis and performing additional experiments to assess the
potential of molecules or immunotherapies that target sepsis risk genes and pathways as novel therapies.

Public health relevance
PROJECT NARRATIVE Despite decades of intensive research, sepsis remains a poorly understood condition with high mortality and morbidity and no specific treatments. To narrow this gap, we propose a research program to determine the sepsis-associated genetic variants that affect disease severity or susceptibility independently of sepsis clinical risk factors or behavioral and social determinants of sepsis, and the mechanisms that connect these variants to their function. Achieving these goals will lead to a better understanding of sepsis biology and the identification of novel drug targets.